Internalization of dead cells governs intestinal stem cell activity

ABSTRACT
Appropriate response to injury is critical for epithelial barrier function and organismal health. In order to restore
tissue homeostasis after injury, stem cells must receive signals from their surrounding niche to adjust their
proliferation and differentiation at defined stages of repair. The dynamic mammalian intestinal epithelium is a
well-suited barrier to approach this problem, as it constitutes the first line of host defense against diverse forms
of potentially disease-causing environmental insults and is rapidly replenished by defined populations of
intestinal stem cells (ISCs). Located at the base of crypts of Lieberkühn, ISCs are relatively protected from
these insults, yet need to sense external factors in order to regulate functions including stem cell state,
turnover, and lineage allocation, each critical for maintaining barrier integrity. While certain signaling
mechanisms that maintain some ISCs decisions are known, how ISCs adapt to environment influences that are
durable and communicative to other ISCs is unclear. This proposal tests the hypothesis that ISCs engage
in phagocytosis of dead cells as a means for sensing the health of intestinal tissues in which they
reside, and that this mechanism underlies durable and widespread alterations in stem cell function.
The supporting idea is built off of a surprising, but still untested discovery made half a century ago by pioneers
in this field – that ISCs can engulf dead neighboring cells. Using modern techniques, my preliminary data
support this capability and indicate that ingestion of apoptotic intestinal epithelial cells impacts ISC proliferation
and differentiation. In Aim 1, I will determine the mechanism of ISC uptake of dead cells by employing discrete
and bioactive cargo, spheroids derived from mouse and de-identified human samples, as well as in vivo mouse
models. In Aim 2, I will test the mechanisms by which dead cell engulfment alters ISC function through cutting-
edge lysosomal purification techniques, genetic models, and in vivo models of epithelial injury. The proposed
research will lay the groundwork for understanding fundamental intestinal stem cell biology that forms the basis
of sensing environmental cues that can trigger adaptive responses for maintaining optimal tissue and
organismal health. This knowledge will pave the way for future efforts to understand and leverage key intestinal
stem cell biology as therapeutic targets to address a wide range of disease states.

Public health relevance
PROJECT NARRATIVE Intestinal health relies on an intact single layer of barrier cells that originate from a progenitor population of intestinal stem cells. How these stem cells sense environmental cues in order to make adjustments during infection and damage to maintain a healthy intestinal barrier is poorly understood. This proposal will establish a fundamental mechanism where intestinal stem cells take up dead neighboring cells to regulate their growth, turnover and differentiation, thereby establishing a new for therapeutic discovery in a variety of inflammatory intestinal diseases.